ENDOCYTOSIS, SECRETION AND COMPARTMENTALIZATION IN MUTANT CHO CELLS

An approach to dissecting the processes of endocytosis, glycoprotein biosynthesis and sorting is through isolation and analysis of mutants. Based on observations of aberrant compartmentalization of the M6P/IGFII receptor in a temperature-sensitive End1 mutant, perturbation of the intracellular pathways followed by this receptor was attempted. Summarizing these results: 1. In the presence of weak base human diploid fibroblasts accumulate up to 40% of receptor-enzyme complexes in dense lysosomes; this accumulation represents a steady state and is rapidly reversed upon re-acidification of organelles. 2. Inhibition of protein synthesis effects rerouting of lysosomal enzymes present in the secretory pathway from a predominantly intracellular to a predominantly endocytic route of delivery to lysosomes. 3. Inhibition of protein synthesis also blocks accumulation of receptor-ligand complexes in lysosomes and effects a futile cycle whereby these complexes shuttle between the cell surface and an intracellular compartment(s). It is hypothesized that a rapidly turning-over protein is required for delivery of receptor-enzyme complexes to the late endosome via both the endocytic and intracellular pathways. Electron microscopic examination of endocytosed tracers in a CHO cell mutant isolated for its accumulation of ligand in non-acidic vacuoles indicates that the mutant may be impaired in vesicular fusion.